INTERACTION BETWEEN HORMONE REPLACEMENT THERAPY AND EXERCISE--POSTMENOPAUSE

The objective of this study in postmenopausal women is to determine if (a) hormone replacement therapy (HR) and endurance exercise training independently result in improvements in cardiovascular (CV) function, CV disease risk factors, body composition, and bone density in postmenopausal women and (b) combining HRT and exercise training results in even greater beneficial adaptations in these same variables.